Development of Biosensor Technology for Protein Interactions

In collaboration with Dr. Michael Tarlov, we have further investigated the optimal sensing layer design for the characterization of the carbohydrate moiety of glycoproteins. This resulted in the recognition that multi-valency of lectins is an important factor in the choice of immobilization strategy. Previously we had recognized surface site heterogeneity is a key problem of surface binding analysis, and developed a method for extracting affinity and kinetic rate distributions from experimental data. For this purpose we had programmed a software tool that is now widely used. We have now further improved this program by facilitating the application of corrections for mass transport limited binding, broadening the applicability of this approach.